Ohio's FFM and Dietary Supplement Project Proposal

MFRPS MAINTENANCE PROJECT SUMMARY/ABSTRACT
RE: Flexible Funding Model-Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Programs (U2F) Clinical Trials Not Allowed (Funding
Opportunity Announcement (FOA) Number RFA-FD-23-027).
The overall goal of the Ohio Department of Agriculture, Division of Food Safety (ODAFS) is to
achieve and maintain conformance with the most current version of the Manufactured Food
Regulatory Program Standards (MFRPS), which are intended to enhance food safety by
establishing a uniform basis for measuring and improving the performance of manufactured
food regulatory programs in the United States and help Federal and State programs better
direct their regulatory activities at reducing foodborne illness hazards in plants that
manufacture, process, pack, or hold foods. The participation of ODAFS in the Flexible Funding
Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory
Programs (U2F) cooperative agreement will assist the program as it continues to develop and
maintain best practices for a high-quality regulatory program. In addition to maintaining
conformance with the MFRPS, ODAFS has intentions of developing a state driven dietary
supplement regulatory framework and program through training and other program
development activities to advance the adoption and implementation of 21 CFR Part 111 cGMPs
for Dietary Supplements Rule.

Public health relevance
MFRPS MAINTENANCE PROJECT NARRATIVE RE: Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs (U2F) Clinical Trials Not Allowed (Funding Opportunity Announcement (FOA) Number RFA-FD-23-027). There are now approximately 4,196 manufactured food facilities in the Ohio Department of Agriculture, Division of Food Safety’s (ODAFS) inventory. In the 12-month period of 8/15/21 – 8/14/22 our program conducted a total of 2,049 inspections consisting of routine inspections and follow-up inspections, with a total of 247 compliance actions taken which included the issuing of Notices, embargoing product, and voluntary destructions of product. The participation of ODAFS in the Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs (U2F) cooperative agreement will assist the program as it continues to develop and maintain best practices for a high-quality regulatory program, partnering with industry and other State, Federal, and local regulatory agencies to protect public health and safeguard the food supply.